ARISE (Achieving Routine Intervention and Screening for Emotional health)

ABSTRACT
Diabetes mellitus (DM) affects 30 million people in the U.S. African-Americans and Hispanics are 1.4 and 1.2
times more likely to have DM compared to non-Hispanic whites. Diabetes distress—stress, fear, and guilt
related to managing diabetes—is linked to poor glycemic control and disproportionately affects African
Americans and Hispanic adults with type 2 diabetes mellitus (T2DM). The American Diabetes Association
(ADA) has published guidelines promoting screening for and addressing diabetes distress (DD) as a critical
part of clinical care. However, only 24% of adults with diabetes report their health care team asked them how
diabetes affected their lives. Efforts to systematically identify and address DD could be an important strategy to
improve diabetes outcomes among disadvantaged populations and address diabetes disparities. Community
health centers (CHCs) can be important partners in this effort; CHCs provide primary care for 2.5 million adults
with diabetes. More than 70% of CHC patients have income below 100% of the federal poverty level and 57%
are people of color. No studies have systematically implemented DD screening and treatment interventions
into a real-world primary care setting or used a guideline based approach. To fill this gap, we developed the
ARISE (Achieving Routine Intervention and Screening for Emotional health) intervention. Based on published
guidelines, ARISE incorporates validated screening instruments, draws from interventions shown to improve
DD and is individualized to patients’ domains of DD. ARISE includes a standardized process for screening
adult patients with T2DM for DD, training for health center staff on how to address distress in the patient
encounter, and an algorithm for action steps and referrals based on the domains identified as sources of
distress. This study aims to compare ARISE to enhanced usual care (didactic training for health care teams on
DD) in CHCs using a type I hybrid effectiveness-implementation design via a cluster randomized pragmatic
trial. First, we will adapt ARISE into clinical workflows in two CHCs (one urban and one rural) using the Form
and Function domains of the Complex Health Intervention Framework. Using the lessons learned from the
adaptation, we will conduct a cluster randomized pragmatic trial across 12 CHCs (six ARISE and six enhanced
usual care) to test ARISE vs. enhanced usual care among adult patients with T2DM and A1c>8%. Primary
outcome will be change in A1C from baseline to 12-months between arms. Secondary outcomes will include
change in DD from baseline to 6-months within the ARISE arm and change in patients’ systolic blood pressure,
low density lipoprotein (LDL), and body mass index (BMI) across the two arms. We will assess the adoption,
implementation, and maintenance of the ARISE intervention. We will use knowledge gained to develop best
practices for CHCs across the country that are charged with caring for the largest share of America’s medically
vulnerable patients with T2DM.

Public health relevance
NARRATIVE Diabetes distress—stress, fear, and guilt related to managing diabetes—is linked to poor glycemic control and disproportionately affects vulnerable populations. Screening for and intervening on high levels of diabetes distress is now a part of diabetes care guidelines, but no studies have tested diabetes distress screening and treatment interventions in a real-world primary care setting. This pragmatic study will compare a program to support community health center (CHC) healthcare teams deliver systematic diabetes distress screening and intervention (6 CHCs) to enhanced usual care (6 CHCs) and assess its impact on glycemic control (A1C) among adults with type 2 diabetes.